Multi-isotope Hybrid PET/CT/ Imaging of Peripheral Artery Disease in Diabetes: Diversity Supplement Post Doctoral Training

Summary
The purpose of the proposed research is to facilitate learning experiences in a two-year post-doctoral.
training experience, connecting the intersection between learning novel imaging algorithms to risk stratify
individuals with high-risk Peripheral Artery Disease (PAD) as well as their clinical validation and association with
clinically relevant outcome measures. In addition, this grant is also looking to provide opportunities for
underrepresented background post-doctoral, Dr. Tapia. She will be a part of the development of this project and
will be supported with the tools and opportunities to learn this scientific/research pathway with the principal goal
of empowering her for an independent project in the future. Integration of professionals with diverse backgrounds
is the way to create and develop research projects with the vision to provide better outcomes for the community.
Peripheral Artery Disease (PAD) poses a significant growing public health concern, with millions
worldwide affected by progressive functional decline. Association with other comorbidities such as Diabetes
Mellitus (DM) creates a challenging approach diagnostically and treatment-wise. Our proposed research seeks
to get a better understanding of how the pathophysiology and adaptations at the microvascular levels for PAD
and DM are seen. With imaging dual isotope (82Rb/18F-LMI1195) hybrid Positron Emission Tomography (PET)/
Computerized Tomography (CT) these imaging techniques are great options for these patients, helping the future
approach and treatment.
Amis 1A, 1B, and 2 will be focused on understanding the technical aspects of PAD, as well as how the
different imaging procedures will give us a better understanding of this condition. Aim 3 will be directed to validate
the data using the PORTRAIT and SCOPE-CLI study designs. Data recollection will allow us to evaluate imaging
protocols in a real-world population and correlate risk profile information with imaging characteristics validating
the imaging protocols, while also generating further hypotheses. The proposed project represents the
implementation of a new imaging protocol and generating benefits in the approach and treatment of this chronic
condition, PAD.
The training position will span over a period of 2 years, during which it will be involving a combination of
the pre-clinical aspect in animal models, and then screening in human subjects. Accurate quality control
measures in the image acquisition and data recollection period as well as the multidisciplinary collaboration will
be needed to achieve high-quality outcomes and robust validation and translational potential.
In conclusion, this proposal ambitions to enhance Dr. Tapia's learning experience by integrating new
knowledge and research skills. It will also involve the development and implementation of imaging protocols for
future approaches and treatment of PAD and DM.

Public health relevance
Narrative This research aims to enhance learning skills in a two-year post-doctoral training by promoting diversity and integrating varied backgrounds, and skills. Focused on novel imaging algorithms, the study looks for to stratify high-risk Peripheral Artery Disease (PAD) subjects, validate findings, and improve patient management.